Interrogating the role of BLTP3A in organizing protective immunity in ovarian cancer

ABSTRACT
Epithelial ovarian cancer is the deadliest gynecological malignancy in the U.S., with advanced high-grade serous
ovarian cancer (HGSOC) patients facing a 5-year survival rate of about 30%. Although T cell infiltration into tumor
epithelial islets is linked to prolonged survival, the mechanisms behind these protective immune responses
remain poorly understood. My dissertation investigates the tumor cell-intrinsic role of a novel tumor
microenvironmental stress-response molecule, BLTP3A, in HGSOC. We identified a germline nonsynonymous
SNP, rs13205210 (M1098T), in BLTP3A that is associated with a dramatic survival benefit for HGSOC patients.
This mutation is also linked to the development of systemic lupus erythematosus (SLE), suggesting M1098T
BLTP3A may provoke enhanced antitumor immunity in HGSOC. Under Dr. Payne's supervision, I demonstrated
that HGSOC tumors expressing M1098T-BLTP3A exhibit elevated effector T cells within tumor beds. To elucidate
BLTP3A's function, I confirmed its elevated expression in malignant epithelial cells and generated a conditional
Bltp3a knockout mouse model. Remarkably, Bltp3a-ablated tumors showed superior survival through a CD8+ T
cell-dependent mechanism. Mechanistically, we discovered that BLTP3A interacts with RAB7 and the HOPS
complex, acting as a RAB7 effector that may promote autophagosome-lysosome fusion. As such, Aim 1 of this
proposal focuses on unraveling the mechanisms by which BLTP3A influences immune cell dynamics, within the
tumor microenvironment. During the F99 phase, I will receive rigorous training under Dr. Payne’s mentorship in
single-cell data analysis, enabling high-resolution profiling of tumor-infiltrating immune cells. Additionally, I will
work closely with Dr. Sant’Angelo and Dr. Payne to gain expertise in secretome and proteomics analyses,
mapping immune signatures modulated by BLTP3A ablation. To further understand BLTP3A’s role in
autophagosome and lysosomal fusion, I will train in Dr. White's lab. Mastering these advanced methodologies
will equip me with the skills for conducting complex, integrative analyses, essential for my transition to
independent research during the K00 phase. A critical skillset gap that Aim 2 will address is my ability to
thoroughly investigate immune cell interactions within the ovarian tumor microenvironment, leveraging advanced
spatial transcriptomics alongside multi-omics approaches, with a focus on proteomics and metabolomics. To
bridge this gap, I will seek a postdoctoral lab equipped to provide training in both foundational and state-of-the-
art techniques during the K00 phase. This work will establish a robust mechanistic framework for understanding
BLTP3A’s role as a regulator of tumor microenvironment interactions, while also advancing my journey toward
independence as a cancer immunology investigator

Public health relevance
Project Narrative Ovarian cancer is the deadliest gynecological disease in the United States. Although T cells in the ovarian carcinoma microenvironment can spontaneously exert clinically relevant pressure against malignant progression, current immunotherapies rarely induce the regression of ovarian cancers. The work detailed in this proposal will elucidate the mechanisms by which the poorly characterized molecule, BLTP3A, restrains protective immunity in ovarian cancer; gaining this mechanistic insight will pave the way for the design and development of rationale combinations of more effective immunotherapeutic agents for ovarian, and likely other, cancers.